DOSE - RESPONSE STUDY OF GUANFACINE IN ALZHEIMER'S DISEASE

To improve attention, memory or mood in subjects with Alzheimer's Disease by administering guanfacine, a drug that decreases noradrenergic turnover.